Universal, high-throughput platform for multi-omic analysis of tissue samples with single-cell spatial resolution

ABSTRACT The development of technologies for single-cell analysis has strong impact on human health. Currently, around 1,300 clinical trials are in process to introduce the single-cell analysis in clinical practice for various types of cancer and infectious diseases. The goal of the proposed STTR project is the development of a high-throughput transcriptomic platform with multi-omic potential with spatial resolution at a single-cell and sub-cellular level.

Public health relevance
Project Narrative We propose to develop a universal high-throughput platform for single-cell analysis by combining microcapillary plates & addressable barcoding/target sequence technology. With continuing reduction of DNA sequencing cost, more and more newly developed biological tests ultimately rely on acquisition of information from massive DNA sequencing. The proposed platform will enable the creation of a variety of new, highly economical biological tests (e.g. wide population genomic studies, multi-omic tumor profiling, simultaneous, multi-omic profiling of liquid and solid tumors and the surrounding immune cells, progenitor cells, microphages and other cell types).